Social Stress, Epigenetics and Cardiometabolic Health Among Youth

Project Summary
There is extensive evidence that economic and social stressors shape the development of cardiovascular
disease starting early in the life course. However, it is largely unknown how social and economic stressors
affect biological processes, particularly at the cellular level and whether these processes are evident
among children and adolescents. Latinos, the largest and fastest growing ethnic minority group in the
United States, have a high prevalence of cardiovascular risk factors and experience higher rates of poverty
and social stressors in both childhood and adulthood compared to other racial/ethnic groups. One novel
method to evaluate possible mechanisms underlying the associations between stressors and
cardiovascular health across the life course is DNA methylation. Recently a handful of small studies have
found that stressful experiences may alter DNA methylation, thus providing a potential mechanism by
which social stressors may get under the skin. We propose to examine the association between social
stressors, in relation to DNA methylation, mitochondrial DNA (mtDNA) damage and cardiometabolic health,
among children participating in the Hispanic Community Health Study /Study of Latinos (HCHS/SOL) Youth
Study. The HCHS/SOL Youth study is a study of US Latinos, representing varied countries of origin,
conducted in the US. We propose to use existing data from 1200 participants who completed the HCH/SOL
Youth study and who provided blood samples. Existing blood samples will be assayed for DNA methylation
age, genome-wide methylation and a mtDNA damage marker. Cardiometabolic health markers (obesity,
diabetes, hypertension, inflammation and lipids) have also been assessed. Existing data also includes
assessments of current family environment as well as socio-cultural factors among children. Specifically,
we will examine 1) whether social and economic stressors are associated with DNA methylation age,
mtDNA damage and genome-wide methylation; 2) whether DNA methylation age, genome-wide
methylation and mtDNA damage is associated with cardiometabolic health among children and 3) whether
socio-cultural factors (i.e, ethnic identity, parental closeness, place of birth) modify the association between
social and economic stress and DNA methylation and mtDNA damage association. We will furthermore
implement mendelian randomization techniques to address the cross-sectional nature of the data.
Completion of this project would allow us to elucidate the impact social and economic stressors have on
epigenetic and cardiometabolic markers that may help explain how stress shapes persistent population
health disparities among Latino populations.

Public health relevance
Project Narrative Social and economic stressors are increasingly recognized as important factors that shape the development of cardiovascular disease particularly among Latinos, who experience a disproportionate burden of these factors across the life course. However, the pathways through which social and economic stressors affect the biological pathways related to health disparities are not fully understood, particularly at the cellular level, and little research to date has examined how these factors impact cardiovascular markers early in the life course. We propose to address these gaps by examining how social and economic stressors experienced in childhood impact DNA methylation (e.g. DNA methylation age, genome-wide methylation) and mtDNA damage, among a diverse sample of Latino youth living in the US, as well as how these factors may impact their cardiometabolic health.